GENETIC FACTORS AND THE ETIOLOGY OF ALZHEIMER'S DISEASE

Based on the premise that genetic factors may influence predisposition to late onset Alzheimer's disease, molecular genetic linkage in being sought in three regions of the genome.